Interplay of Affect and Physiology in the Real-Time Prediction of Return to Use During Community Reintegration of Substance Users

PROJECT SUMMARY/ABSTRACT
More than four million U.S. residents seek treatment for substance use disorder (SUD) each year.
Community reintegration following residential SUD treatment is an especially vulnerable time, withmost people
who return to use following residential SUD treatment doing so in the 30 days immediately following discharge.
D
during
information
aily monitoring methods such as ecological momentary assessment (EMA) can identify higher risk periods
community reintegration as well as clarify time-sensitive proximal predictors of return to use. This
can help tailor the type, amount, and timing of interventions to prevent and/or delay return to use.
of substance use afterEscape from and avoidance of negative affect are leading motives for re-initiation
periods
of
abstinence.
These data underscore affect dysregulation—a widely regarded transdiagnostic risk
factor—as a key target for interventions to be delivered during community reintegration of SUD inpatients. Yet,
knowledge/methodological/population gaps limit our understanding of affect dysregulation in SUD. (1) Virtually
all research on return to use during community reintegration has used cross-sectional or traditional longitudinal
designs. Pinpointing real-time proximal predictors of return to use is necessary to inform interventions that can
be delivered when
dysregulation
and
use
of
Studies in this area have exclusively focused on dysregulation stemming from negative affect. Positive
dysregulation
SUD
individuals are most in need or may most benefit from them. (2) Our understanding of affect
in risk for return to use i s limited. Intensive longitudina l data methods (e.g., EMA) capture within-
between-person affect dynamics, which may improve detection of individuals a greatest risk for return to
as well as pinpoint risk states to intervene on in momentary interventions. They also allow for examination
potential clinical targets for momentary interventions, such as engagement in affect regulation strategies. 3)
affec
may also increase risk for return to use during community reintegration. (4) Individuals in early
recovery exhibit autonomic dysfunction; thus, HRV may be an important bio-signal for detecting
t
(
t
risk for
return to use during community reintegration. (5) Community reintegration is a period of unique/intense stress
for people with SUD. Research during this period is severely limited. Studies must examine whether findings to
inform interventions for this population will be useful for most people who experience community reintegration.
Addressing these critical gaps, we propose integration of subjective data from EMA with physiology from
the Empatica Embrace2, collected in individuals' (N=300) natural settings during the 30 days after residential
SUD treatment. Aim 1 identifies features of negative and positive affect dynamics that predict return to use
outcomes during community reintegration of SUD inpatients. Aim 2 tests theutility of physiology from a
wearablebiosensor in detecting return to use. Aim 3assesses the extent to which features of affect dynamics
and physiology proximally predict return to use across diverse demographic and clinical groups.
Findings will inform evidence-based tools to prevent/delay return to use during community reintegration.

Public health relevance
PROJECT NARRATIVE Community reintegration time following residential substance use disorder (SUD) treatment is a critically vulnerable that is characterized by high rates of return to use. This proposal will technologiesuse cutting-edge to identify time-sensitive proximal predictors of return to use during community reintegration. This knowledge is needed to develop evidence-based tools to prevent and/or delay return to use during community reintegration.